Transforming growth factor β family signaling pathways in ovarian and uterine biology

PROJECT SUMMARY
Transforming growth factor β (TGFβ) family signaling pathways function in normal physiology and diverse
reproductive tract diseases including infertility, preeclampsia, and endometriosis. There are 33 TGFβ family
ligands, and these proteins act as either homodimers [e.g., bone morphogenetic proteins (BMPs), activins, and
nodal] or heterodimers (e.g., inhibins and GDF9:BMP15). These dimeric ligands signal from the cell surface to
the nucleus by assembling heteromeric serine-threonine kinase receptor complexes that include two type 1
receptors [known as activin-like kinases (ALKs)] and two type 2 receptors. With 33 years of support from
NICHD, we have defined the in vivo roles of TGFβ family ligands, receptors, binding proteins, SMADs, and
downstream proteins in the female and male reproductive tracts, created over 300 mouse models for studying
human fertility, published over 170 papers to genetically and chemically interrogate these signaling pathways
in development, physiology, infertility, and cancer, and have begun to generate the first specific kinase
inhibitors of the TGFβ family receptors. In particular, whereas mammalian oocytes were initially thought to be
merely passengers rather than drivers in ovarian development, we discovered that growth differentiation factor
9 (GDF9) and bone morphogenetic protein 15 (BMP15) are essential oocyte-secreted TGFβ family ligands in
the regulation of female fertility in mammals that bind a unique receptor signaling complex. We hypothesize
that specific small-molecule regulators of GDF9:BMP15, activin, BMP, and nodal signaling can be used to
manipulate fertility pathways and modulate ovarian and uterine functions in vitro and in vivo. The overall
translational goals of this R01 renewal are to use mouse models, ALK-specific small molecules, and
recombinant protein strategies to genetically manipulate, chemically modulate, and structurally characterize
GDF9:BMP15, activin, BMP, and nodal signaling pathways in the mammalian ovary and uterus. Our 5-year
studies will create an assortment of drug-like molecules that can either block or stimulate TGFβ family
signaling pathways, thereby serving as non-hormonal contraceptives or as treatments for infertility,
preeclampsia, and endometriosis in the clinic.

Public health relevance
NARRATIVE Our studies are aligned with the missions of the National Institute of Child Health and Human Development and research into reproduction, contraception, and population control because transforming growth factor β (TGFβ) superfamily signaling pathways play essential roles in a diversity of developmental and pathophysiological processes including those related to reproductive disorders. Our studies will improve the women’s reproductive health, better the quality-of-life for both women and their offspring, advance the diagnosis and treatment of reproductive health conditions, such as infertility, endometriosis, and preeclampsia, and contribute to the development of better contraceptive therapies for women. The long-term objective of this R01 renewal is to develop drugs that can either stimulate or block TGFβ superfamily signaling pathways in the ovary or uterus, thereby enhancing fertility or serving as the first non-hormonal contraceptives for women.